Limited Competition for the Continuation of the Chronic Renal Insufficiency Cohor

DESCRIPTION (provided by applicant): Between 2003-20013, the prospective Chronic Renal Insufficiency Cohort (CRIC) Study enrolled 3939 adults with chronic kidney disease to address overarching goals of identifying predictors of rapid progression of kidney disease and clarifying the relationship between kidney dysfunction and the risks of subclinical and clinical cardiovascular events, death. The third phase of CRIC extending follow-up through 2018, and recruiting a new cohort of participants offers a unique opportunity to leverage the existing effort and success of CRIC to establish a cohort of participants with chronic kidney disease who have long-term prospective follow-up on progression of kidney disease and a variety of different outcomes. This unparalleled resource will also expand the science related to chronic kidney disease natural history as well as the impact on cardiovascular disease and other adverse events. Specific Aims to be addressed by the Case Western Reserve University Clinical Center are: 1. To re-enroll a high percentage of current CRIC participants into Phase 3 of CRIC 2. To recruit 215 new participants meeting eligibility criteria defined by the study protocol 3. To collet exposure and outcome data per the CRIC protocol 4. To maintain high levels of retention in the study, 5. To investigate self-reported clinical events and obtain supporting medical records and documentation, 6. To enter data and process/ship biological specimens. 7. To implement local quality assurance and quality control procedures as a means to obtain standardized, high quality measurements 8. To monitor data collection, data entry, and follow-up rates 8. To participate in the overall governance and oversight of the CRIC study through active involvement in study wide subcommittees and activities 9. To publish and present findings from the CRIC Study 10. To promote and support the conduct of ancillary studies in CRIC, including collaboration with the broader nephrology research community.

Public health relevance
PUBLIC HEALTH RELEVANCE: The CRIC study is designed to study the reasons why kidney disease progresses over time, and to identify factors that contribute to development of heart disease. Over the last 10 years, this study has established an impressive infrastructure; we now propose to extend this study for another 5 year period and also recruit a new cohort of patients with early kidney disease. This will help advance our understanding of early kidney disease particularly in older patients.